Impact of TBI and Cognitive Decline on Alzheimer's Disease Brain-Derived Exosome Cargo

PROJECT SUMMARY ABSTRACT
Exosomes remove proteins and cellular substituents, and also shuttle protein cargo between cells and also to
the periphery. Unlike freely circulating proteins, exosomes are identified by surface markers that include
designations of cell type origin. Astrocyte and neuronally-derived exosomes (ADEs and NDEs, respectively)
from plasma are identified by specific membrane markers, providing an accessible substrate to identify
biomarkers and mechanisms of neuropathology. The potential for NDEs to identify TBI-related biomarkers
however is just beginning to be explored.
Our lab has a large focus on exosome biomarkers in TBI and neurodegeneration. Our data demonstrate
that Alzheimer's disease (AD) neuropathological proteins, amyloid-beta and phospho-tau are sequestered in
NDEs and are more sensitive biomarkers of AD than free proteins in native plasma. In terms of Veterans with
TBI, we and others have found that NDEs have increased levels of Aβ, proteins associated with neuronal injury
and synaptic proteins. We have also shown that complement protein cargo in ADEs is also associated with
AD. Although exciting, these studies represent relatively small studies in samples from younger individuals
with limited information about the relationship between exosome protein cargo and functional changes. To
examine CNS-enriched exosome proteins as biomarkers of TBI and associated cognitive decline in older
individuals, we will leverage banked plasma samples from the Vietnam Era Twin Study of Aging (VETSA), a
longitudinal cohort study of US Veterans who had a mean age of 56 at the first assessment wave and 67 at the
most recently completed third assessment. In this Merit Award proposal we propose to determine the utility of
neurodegenerative disease proteins within NDEs as biomarkers to predict cognitive change in aging twin
Veterans with post-traumatic stress disorder and TBI and also to identify the mechanisms underlying the
relationship between inflammatory pathways, cognition and neurodegeneration associated with TBI and PTSD
in VETSA. Our overarching hypothesis is that remote TBI is associated with abnormalities in cytoskeletal and
neuronal proteins in circulating NDEs. We also hypothesize that remote TBI causes chronic changes in central
inflammatory tone which leads to abnormalities in complement and cytokine proteins in circulating ADEs

Public health relevance
PROJECT NARRATIVE Exosomes are secreted vesicles that are released from most types of cells including neurons. Data from our lab and others demonstrate that neuronal exosomes are a readily detectable in blood, and are promising tools for aiding diagnosis of neurodegenerative disorders, such as Alzheimer's Disease (AD). This project will determine if circulating proteins carried in neuronal exosomes have utility as biomarkers for neurodegeneration and how this is impacted by TBI, PTSD in twins from the VETSA Study.